Developing DNA-Based Molecular Robots

SUMMARY
The majority of medical diagnostic and therapeutic procedures depend on invasive methods and
sophisticated tools. These medical practices are non-convenient for the patients, are expensive, are time-
consuming, and require intensive use of equipment and professional resources. Therefore, there exists a
critical need for medical devices and procedures that minimize the inconvenience, cost, and resource
allocation. The PI's long-term goal is to develop intelligent molecular robots that detect diseases and treat
them by providing appropriate responses that are timely, inexpensive, and convenient.
PI's overall objectives for the proposed project are to construct a prototype of the envisioned robot, produce
the preliminary data that will support submitting a targeted R01 grant at NIH, and establish a translational
research program with support from his team. The PI's team will build a programmable DNA-based robot
that aims at i) detecting specific RNA molecules and ii) generating amplified signals and select gene
products. Leveraging PI's background, qualifications, and expertise that this proposal will advocate and the
strong team he has assembled, he and his team are well-positioned to pursue this research. The proposed
idea is likely to succeed because the PI's preliminary data demonstrates the project's feasibility. As a proof
of concept, the team will design the robot to detect specific microRNA molecules that are known markers
of breast cancer cells. The robot responds to the existence of the microRNAs by overexpressing the
accompanying therapeutic gene. Modifying and altering domain properties of DNA-based molecular
machines are inexpensive, fast, and efficient. Hence, the proposed work potentially has a broad reach –
given the team can readily change the robot to enable detection of a host of biomolecules, including but not
limited to various microRNAs. To achieve the goal of the proposed project, the PI will address the following
three specific aims:
• Aim 1: Design, construct, and characterize the robot's structural, optical, and functional properties,
resulting in the construction of an efficient robot.
• Aim 2: Develop target specificity and demonstrate the robot's diagnostic and therapeutic capabilities
that enable both colorimetric detection and elimination of the target cancer cells.
• Aim 3: Establish a vigorous translational research program and involve students in the research,
provide mentorship and training for students to train the impactful workforce, scientists, and leaders
of the future; in alignment with the mission of NIH.
If successful, the proposed research will result in preliminary data that informs larger grant applications to
develop molecular robots that perform diagnostic and therapeutics.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because it will result in a series of preliminary data that will inform future grant applications that aim to develop inexpensive and fast molecular robots to diagnose and treat diseases. The proposed robot will detect breast cancer microRNAs and regulate the expression of select genes that serve as therapeutic agents. If successful, the robot enables more convenient means of theranostics, and since RNA molecules are linked to many diseases, the robot has a broader reach than cancer medicine.